Predoctoral Training in the Genetics of Development, Disease and Regeneration

PROJECT SUMMARY / ABSTRACT
The Genetics of Development, Disease, and Regeneration Training Program seeks to foster a broad
foundation of interdisciplinary knowledge and career development that empowers a diverse population of
students to apply their training to the study and treatment of developmental diseases. To achieve this goal, the
GDDR Program is grounded in five training fundamentals: 1) knowledge base, 2) research skills and innovative
technology, 3) hypothesis-driven research, 4) communication skills and 5) professional and career
development. The GDDR Program creates a unique training environment by combining the broad and
interdisciplinary research interests of our faculty with a training plan that integrates genetic principles and
mechanisms into the study of development and stem cell biology. Thirty well-funded and accomplished
Training Faculty drawn from 10 basic science and clinical departments create a highly collaborative and
interdisciplinary environment. This proposal for supplemental support through the INCLUDE Project seeks to
provide trainees with better access to the resources and intellectual/technical expertise present in Crnic
Institute and Crnic Supergroup at the University of Colorado, in order to equip young scientists with the
technical and professional skills necessary to conduct rigorous and reproducible research with a focus on
Down Syndrome. Trainees supported by this supplement will participate in all the activities that are designed
for other GDDR T32 trainees, thereby amplifying the impact of supplement support by integrating Down
syndrome topics and training into the larger GDDR Training Program. We request that three students be
supported for one year as part of the INCLUDE supplement.

Public health relevance
Project Narrative The goal of this training program is to train a diverse group of scientists to solve problems relevant to human health, including developmental diseases. Predoctoral students will learn to responsibly conduct research in genetics, developmental, cell and stem cell biology and gain important communication and professional skills.